3D Bioprinting Shared Facility for Advancing Interdisciplinary Research at the University of South Carolina

Project Summary/Abstract
The University of South Carolina (USC) seeks to establish a state-of-the-art 3D bioprinting shared facility,
equipped with an advanced CELLINK bioprinting system to significantly enhance and modernize research
capacity in biomedical sciences. This system will consist of three core components: the BIO X6, a versatile
extrusion-based bioprinter with six printheads allowing for simultaneous deposition of multiple biomaterials; the
BIONOVA X, a high-throughput digital light processing (DLP)-based bioprinter for rapid fabrication of complex
3D structures; and the LUMEN X, a high-precision, light-based bioprinter designed to create intricate
microarchitectures such as vascular networks. This integrated system will enable the creation of physiologically
relevant, multi-cellular tissue constructs, addressing critical gaps in USC's current research infrastructure and
advancing research operations to a new level of sophistication and efficiency.
The acquisition of this cutting-edge technology will enhance USC's research capabilities in critical areas such as
tissue engineering, regenerative medicine, personalized therapeutics, and disease modeling. It will directly
benefit multiple NIH-funded projects, including studies on cardiac tissue engineering, muscle regeneration, and
neurodegenerative diseases. The system will allow researchers to create complex 3D tissue constructs,
incorporating multiple cell types and biomaterials to replicate the heterogeneity of native human tissues. This
capability is particularly important for the development of more accurate models for drug efficacy and toxicity
testing, which are essential to reducing reliance on animal models and accelerating drug discovery pipelines.
Furthermore, the ability to generate vascularized tissue constructs will enhance USC's ongoing research in fields
like cardiovascular disease, cancer, and neurodegenerative disorders.
The 3D bioprinting facility will be a shared resource, managed by the Office of the Vice President for Research,
promoting interdisciplinary collaboration and cost-effective research across multiple academic units, including
Molinaroli College of Engineering and Computing, School of Medicine, College of Pharmacy, College of Art and
Sciences, and the Arnold School of Public Health. USC is committed to supporting this facility with dedicated
staff and resources to ensure its long-term sustainability and optimal utilization. It will serve as a hub for training
graduate students, postdoctoral researchers, and faculty in cutting-edge bioprinting technologies, enhancing
USC's competitive position in securing high-impact research grants. Long-term, the facility aims to significantly
strengthen USC's position in biomedical research by enabling the development of advanced tissue models,
improving the efficiency of preclinical research, and fostering innovations in tissue engineering and regenerative
medicine that have the potential to inform future clinical applications.

Public health relevance
Project Narrative The proposed 3D bioprinting shared facility at USC will significantly enhance biomedical research capabilities relevant to public health. By enabling the creation of more accurate 3D tissue models, the facility will support improved studies of diseases and testing of new therapies. These advanced models have the potential to accelerate drug discovery processes and reduce reliance on animal testing. Over time, research conducted using this facility could contribute to the development of more effective treatments for conditions such as cancer, cardiovascular disease, and neurodegenerative disorders, ultimately supporting efforts to improve public health outcomes.